Brain capillary Piezo1 ion channels and blood flow regulation in Alzheimer’s Disease

Summary:
Brain capillary Piezo1 ion channels and blood flow regulation in Alzheimer’s Disease
Brain capillaries are the smallest blood vessels in the brain and are crucial in sensing the metabolic needs of
active neurons and responding to these needs by supplying more blood. Notably, this function is impaired during
neurodegenerative diseases such as Alzheimer’s disease. Not only that capillary sensing is impaired during
Alzheimer’s disease, vascular stiffness and complete disruption of capillary blood flow, referred to as capillary
stalling, have been observed in mouse models of Alzheimer’s disease. Given that capillary stalling disrupts the
hemodynamic forces that capillaries are exposed to, it is important to understand whether Alzheimer’s disease
associates with altered mechano-sensing abilities. We recently discovered that the protein Piezo1 is a
mechanosensor in brain capillaries. Here, we test the overall hypothesis that altered Piezo1 channel activity is
involved in the reduction of brain blood flow in Alzheimer’s disease. We further speculate that tuning Piezo1
activity will improve cerebral blood flow. We will investigate the contribution of endothelial Piezo1 channels to
capillary stalling and blood flow reductions in a mouse model of Alzheimer’s disease. Using capillary endothelial
cells from wild-type and Alzheimer’s disease mice, we will employ innovative electrophysiological and molecular
approaches to assess whether Piezo1 ion channel expression and function are altered during Alzheimer’s
disease. In the second aim, we will utilize in vivo high-resolution, two-photon microscopy to investigate capillary
stalling and blood flow changes in Alzheimer’s disease mice while pharmacologically manipulating Piezo1
channels. This novel work could lead to new therapeutic strategies not previously tested.

Public health relevance
Narrative Blood flow is reduced in small brain blood vessels in patients and mouse models of Alzheimer’s disease, in part due to capillary obstruction that disrupts blood flow dynamics. We discovered that blood flow dynamics are normally sensed by force sensors such as Piezo1, but it is unknown whether these sensors are impaired during Alzheimer's disease. Here, we will use advanced imaging and electrophysiological techniques to study whether Piezo1 function changes during Alzheimer’s Disease and whether restoring its function reduces capillary obstructions and improves blood flow.